Core B: Biostatistics and Data Harmonization Shared Resource

ABSTRACT – Core B, Biostatistics and Data Harmonization Shared Resource
Strong biostatistical leadership and expertise are integral to achieving scientific integrity of research
data and analytical results, and are indispensable for assuring confidence in the potential clinical or public
health impact of research activities. The primary goal of Core B, the Biostatistics and Data Harmonization
Shared Resource, is to oversee and guide all aspects of study design, data management and data analysis
across all three P01 projects so the scientific aims of each project are addressed using standardized, high-
quality datasets and the most appropriate statistical methods. We have a strong team of biostatisticians,
programmer/analysts and investigators with extensive experience using the P01 data and population
resources. Our resources include the California and Utah Cancer Registries linked to hospitalization,
emergency and ambulatory surgery data; the University of North Carolina at Chapel Hill Cancer Information &
Population Health Resource; the integrated healthcare systems of Kaiser Permanente Northern California and
Southern California; and survey data on a population subset. The varying data sources present several
challenges in cleaning, analysis and interpretation, including the potential for reverse causation and various
forms of selection bias. Biostatistical consultation provided by the Core will ensure the appropriate application
of approaches to determine the potential magnitude of such biases and methods to account for them. The
specific aims of the Core are to:
1. Provide overall biostatistical leadership, consultation and support across all three P01 projects and
Core C, the Survey Shared Resource;
2. Carry out cohort identification to meet the subject inclusion criteria for each aim of each project and for
the survey described in Core C;
3. Harmonize and standardize variable definitions used across data sources and projects;
4. Construct and provide study analytic datasets that incorporate data from clinical and administration
data sources, cancer registries, and patient surveys;
5. Oversee analyses using appropriate methods to achieve the aims of each project, including
consideration of systematic biases, potential confounders, and sampling weights in the analysis of
survey data.
To carry out the objectives of this P01, centralized biostatistical expertise and services will ensure use
of common concepts and data definitions throughout the P01. This Core will ensure that data are appropriate
for the questions addressed, harmonized across source data systems to enhance comparability, and analyzed
and interpreted with knowledge of strengths and limitations. This strategy will maximize the potential impact of
P01 findings to inform and improve healthcare for adolescent and young adult cancer survivors.

Public health relevance
CORE NARRATIVE – Core B, Biostatistics and Data Harmonization Shared Resource The Biostatistics and Data Harmonization Core will oversee and guide study design, data management and data analysis across all three P01 projects so that the scientific aims of each project are addressed using standardized, high-quality datasets and the most appropriate statistical methods. The Core will ensure that data are appropriate for the questions addressed, harmonized across source data systems to enhance comparability, and analyzed and interpreted with knowledge of strengths and limitations. This approach will maximize the potential impact of P01 findings to inform and improve healthcare for adolescent and young adult cancer survivors.